Muscle regulation of bone function

Project Summary
The influence of muscle derived molecules on bone remodeling has been for a long time a topic of intense
research in bone biology. Recently we have provided suggestive evidence that interleukin-6 (IL-6) synthesized
in, and secreted in the general circulation by myoblasts, is a powerful and positive regulator of the release of the
bone-derived hormone osteocalcin. Moreover, classical studies of bone cell biology had proposed twenty five
years ago that IL-6 may regulate osteoclast differentiation and some aspects of bone remodeling. In view of
both of these classical and more recent observations, the question arises as to know whether muscle-derived
IL-6 is a biologically important regulator of bone remodeling at rest or during exercise, in young and/or older
mice. A second question is to know whether muscle-derived IL-6 is a significant regulator in vivo of the release
of osteocalcin and therefore of the biological activity of this osteoblast-specific secreted molecule. We intend to
address these two related questions of bone biology in vivo and through the use of several mouse models of
cell-specific deletion for either IL-6 in myoblasts or its receptor in osteoblasts, osteocytes and osteoclasts. To
achieve these goals, the Specific Aims of this application are:
- Determine the role of muscle-derived IL-6 in regulating exercise response and bone mass in vivo.
- Delineate the relative influence of IL-6 signaling in cells of the osteoblast or the osteoclast lineage on
exercise capacity and bone mass in vivo.
- Determine whether acute or chronic delivery of recombinant osteocalcin is sufficient to increase exercise
capacity in wild-type mice as they age.

Public health relevance
Project Narrative The regulation of muscle functions by osteocalcin and of osteocalcin secretion by Interleukin-6 allows to demonstrate molecularly, that a coordinated regulation of muscle and bone function does exist. This project aims at understanding how muscle via Interleukin-6, regulates bone biology. This project may propose novel and adapted therapies for age-regulated bone loss and decrease in muscle functions.